Human Health Exposure Analysis Resource Core: Untargeted Analysis

Project Summary/Abstract (Overall)
Exposures to environmentally relevant chemicals, drugs, medications, and the ingestion of nutrients, and
how they perturb endogenous metabolism have been linked with many types of adverse health outcomes.
Our Hub has the resources, skilled staff, and knowledge to immediately provide Exposome services to
clients of the Human Health Exposure Analysis Resource (HHEAR) Program (RFA-ES-18-012). We initiated
our Untargeted Analysis Core in 2012 through a grant from the NIH Common Fund (C-F) Metabolomics
Program, and have established and applied metabolomics methods to hundreds of studies with over 30
organizations across the United States. These studies have included analysis of a wide range of
biospecimens (e.g., urine, serum, plasma, sweat, feces) with anchors to numerous types of health outcomes
in studies of maternal and child health, kidney disease, cardiovascular disease, obesity and diabetes, and
response to treatment. The success of the NIH C-F Eastern Regional Comprehensive Metabolomics
Resource Core (ERCMRC) led to our establishing a Children's Health Exposure Analysis Resource
(CHEAR) Hub as part of the NIEHS CHEAR Program. Under the CHEAR Program, we successfully
executed our goals, which included a) expanding our services to include high-throughput analysis of the
Exposome using high-resolution Orbitrap mass spectrometry, b) establishing an extensive in-house physical
standards library of exogenous and endogenous compounds run on the untargeted platform, and c)
participating in cross laboratory comparisons to reveal the range of environmentally relevant analytes
identified on our untargeted platform. Our untargeted methods result in tens of thousands of signals that are
annotated by matching to public databases, and annotated and identified against our in-house physical
standards library, using Big Data Analytics. Our core led the development of an evidence-based Ontology
System for the CHEAR Program, which ensures that the confidence in annotations and assignments will be
clearly communicated between Hubs. We have in place over 100 fine-tuned protocols that span the workflow
from receipt of samples through reporting data, and that have quality control/assurance procedures in place
for all steps of the workflow. The HHEAR Untargeted Hub will work within the HHEAR Network and other
HHEAR Hubs, the HHEAR Data Analysis Center (DAC), and the HHEAR Coordinating Center (CC) to
provide client services for Untargeted Analysis, and to work across the consortium to harmonize and
integrate results. The HHEAR Hub will be led under a Multiple PI Leadership Plan by Dr. Timothy Fennell
(Director, Administrative Core and the Development Core), Dr. Susan Sumner (Director, Untargeted Analysis
Resource), and Dr. Xiuxia Du (leader, Computational Exposome workflow). We are ready to provide
untargeted analysis for epidemiology investigations using a wide range of biospecimens and state-of-the-art
technologies, and analysis approaches to reveal the influence of the environment on disease.

Public health relevance
Project Narrative The Human Health Exposure Analysis Resource (HHEAR) Hub will use existing resources and infrastructure developed under the NIH Common Fund Metabolomics Program and the NIEHS-Children’s Health Exposure Analysis Resource (CHEAR) Program to facilitate exposome research, and we will expand our methods for identification of even more compounds that comprise the exposome. Deriving links between environmental exposures and biological responses in humans through understanding metabolic perturbations is critical to the development of intervention strategies.